MicroRNAs in Airway Smooth Muscle Function and Asthma

MicroRNAs in Airway Smooth Muscle Function and Asthma
PROJECT SUMMARY
Over 300 million people, many of them children, suffer from asthma. Airway smooth muscle
(ASM) controls airway narrowing and plays a pivotal role in the pathogenesis of asthma.
Asthmatic ASM becomes hyper-proliferative, increases in size, and may be more contractile.
These phenotypic changes in ASM contribute directly to airway remodeling and airway
hyperresponsiveness (AHR)—cardinal features of asthma. Targeting ASM thus could provide
direct and effective ways to treat asthma but requires deeper understanding of the underlying
molecular mechanisms that regulate the various ASM phenotypes. MicroRNAs are small yet
powerful gene tuners that have the potential to impact diverse cellular processes such as the
ASM phenotypes. My lab has performed multiple functional, phenotype-based screens, using
both microRNA mimics (for overexpression) and focused CRISPR knockout libraries, on the top
100 ASM microRNAs to identify those that directly regulate critical ASM phenotypes, including
proliferation, hypertrophy and contractility. The overarching goal of this proposal is to establish
the in vivo role of top microRNA hits in regulating the corresponding ASM function and AHR,
and to demonstrate that perturbation of such regulation contributes to human asthma and alters
response to asthma therapies. To achieve this goal, we propose multi-disciplinary and
integrative research that combines mechanistic studies in primary ASM cells, in vivo mouse
models, and genetic epidemiology in human asthma populations. Aim 1 will test the targeting of
microRNA-34a and microRNA-432 to reduce ASM mass and AHR. Aim 2 will test the targeting
of microRNA-486 to reduce ASM contractility and AHR. Aim 3 will determine the functional
association of microRNA-34a/432/486 and their target genes with asthma and with responses to
asthma therapy. Results from this study will establish microRNAs as master regulators of
multiple critical ASM phenotypes and provide pre-clinical evidence for further developing
microRNAs-based therapeutics for asthma patients.

Public health relevance
PROJECT NARRATIVE Millions of patients, many of them young children, suffer from asthma with less than optimal therapeutic options. The research is studying how small RNA gene tuners, known as microRNAs, regulate functions of airway smooth muscle cells, which wrap around the airways and contribute to airway flow limitation and asthma. Our study may ultimately contribute to the development of microRNA-based therapy for asthma.